The ecological significance of extended high-frequency hearing in humans

The World Health Organization reports that nearly a half billion people suffer from a disabling hearing loss
worldwide. Hearing loss is typically measured in the standard audiometric frequency range, 250 to 8,000 Hz.
However, the young, healthy human frequency range of hearing extends to about 20,000 Hz. Extended high-
frequency hearing loss (>8,000 Hz) is rarely assessed in the clinic but is a widespread, natural, age-related
condition that begins as early as young adulthood. It is unknown to what extent extended high-frequency
hearing loss affects daily functioning. This proposal assesses the ecological value of extended high-frequency
hearing for speech perception and spatial awareness in realistic settings, which will include spatially separated
talkers having different head orientations in reverberant conditions. There are three specific aims. Aim 1 will
generate a high-fidelity multi-directional anechoic speech database with a representative cohort of adult native
speakers of American English. This database is designed to be used for speech perception experiments and
will be made publicly available. Speech spectral energy across the full range of human hearing will be
examined, as well as the nature of speech radiation toward different directions around the talkers. Aim 2 will
test the effect of simulated loss of extended high frequencies on speech perception and spatial awareness for
listeners with normal hearing out to 16 kHz. These experiments are based on our recent observation that
extended high frequencies in speech provide a benefit for speech-in-speech recognition. We will determine the
magnitude of this benefit in realistic settings and the factors responsible for it. Aim 3 will test the effect of
natural loss of extended high frequencies on speech perception and spatial awareness. Forms of natural loss
that will be studied include hearing loss at extended high frequencies and the wearing of face coverings
(masks) by talkers. The proposed studies will establish the ecological utility of extended high frequencies for
speech communication. Valuable insight will be gained as to how extended high-frequency hearing loss
impacts daily living for otherwise normal-hearing listeners. It is expected that results of the proposed studies
will aid in ongoing efforts to (1) improve clinical measures of hearing loss and (2) improve hearing-aid
processing techniques.

Public health relevance
Worldwide, nearly a half billion people suffer from a known disabling hearing loss, but a larger unknown number of people exhibit extended high-frequency hearing loss (hearing loss above 8,000 Hz). This research will provide valuable insight as to how extended high-frequency hearing loss affects one’s speech understanding in noisy environments and one’s awareness of their spatial surroundings.